Inhaled Aerosol Dosimetry: Advances, Applications, and Impacts on Risk Assessments and Therapeutics

PROJECT SUMMARY/ABSTRACT
The COVID-19 pandemic exposed a critical lack of our understanding the airborne transmission of infectious viral agents.
Deficiencies in understanding the deposition, metabolism, distribution in the body, and mechanisms of injury of aerosols
(particles suspended in a gas) limit the confidence in setting air quality standards and developing new inhaled
therapeutics. The delivered inhaled dose (e.g., mg/target tissues) is poorly understood due to individual differences, the
complexity of aerosols, and post inhalation internal events. UC Irvine’s Air Pollution Health Effects Laboratory has been
involved in basic and applied research in this area since its founding in the School of Medicine in 1974. It has initiated
several topic-focused multi-disciplinary conferences on inhaled aerosols. This proposal requests support for an
international conference “Inhaled Aerosol Dosimetry: Advances, Applications and Impacts on Risk Assessments and
Therapeutics”, to be held adjacent to the UC Irvine campus at the Arnold and Mabel Beckman Center of the National
Academies of Sciences and Engineering, in Irvine, CA 3 days in October of 2024. The conference center offers solid
support including an atmosphere conducive to collegiality, inclusion, and creative thinking. The conference will bring
together scientists, engineers, medical researchers, regulators, and others who normally attend separate professional
meetings, and read specialty journals in relative isolation thereby inhibiting cross-discipline communications and
collaborations. Our Organizing Committee of 10 men and 7 women scientists represents universities, governments, and
private laboratories. They are aware of critical research needs in medicine, science, and government, as well as gender
and racial inequalities. Sessions include; overviews, recent research, complex mixtures; in-vitro methods to reduce the
use of live animals; computer model advances; and case studies. Each session is plenary, geared to be understandable by
all attendees, and each has discussion time. The program supports cross-discipline communication and collaboration.
The registration fee will cover all sessions, and transportation between the nearby airport (SNA), the hotels, and the
conference center. Staff will help those with special needs and efforts will be made to attract those from
underrepresented groups. Students will have a luncheon with prospective employers, and awards will be made for
outstanding student posters. A Proceedings will be published, and a journal issue is planned for those papers that meet
peer review standards. Startup support is provided by our University. The total budget is about $155,000, and $25,000 is
requested from the NHLBI to help support staff and students, and attract attendees from underrepresented groups.
Revised 11-26-2022

Public health relevance
PROJECT NARRATIVE The proposed conference brings relevant specialists (risk assessors, physiologists, aerosol scientists, computer modelers, toxicologists, and medical researchers) together to update our current understanding of inhaled particles and gases, identify critical research needs, form collaborations, and importantly, advance early-career and traditionally underrepresented minority scientists in their careers.